Evaluating the Health Benefits of Workplace Policies and Practices - Phase II

[unreadable] DESCRIPTION (provided by applicant): Although the prevalence of "family-friendly" policies in US workplaces has increased dramatically in recent years, few have been studied using scientifically sound designs. To address this critical gap, NIH and CDC formed the Work, Family, and Health Network (WFHN). During Phase 1, WFHN designed and conducted multiple pilot and feasibility studies. For Phase 2, the WFHN has been called upon to implement an innovative intervention based on Phase I pilot studies that is designed to increase family-supportive supervisor behaviors and employee control over work, and to evaluate the intervention using a group randomized experimental design. The goal of the proposed study is to assess the effects of a workplace intervention designed to reduce work-family conflict, and thereby improve the health and well being of employees, their families, and their workplaces. The study intervention is grounded in theory from multiple disciplines and supported by findings from our pilot/feasibility studies. We will assess the efficacy of the intervention via group-randomized field experiments, one at each of two employers representing different industries. Within each industry partner, 30 worksites of 50-120 employees each will be randomly assigned to intervention or usual practice conditions. All employee and supervisor participants will be assessed at baseline and at 6-, 12-, and 18-months post baseline, including survey interviews and health assessments of cardiovascular risk and sleep dysregulation based on selected biomarkers and actigraphy. Employees' spouse/partners and/or children (one resident child per employee) aged 10-17 years will be assessed to document the impact of the intervention on family functioning. In addition, to provide a more detailed perspective on the temporal relationship of work-family conflict and health, a sub-sample of 500 employee participants and their child will participate in a daily diary assessment including telephone interviews and saliva sampling. Our process evaluation documents details of intervention implementation and dose received by participants. The WFHN will also translate findings to business environments and other public media channels. The study holds great promise for informing the implementation of evidence-based family-friendly policies, and therefore improving the health and well-being of employees and their families nationwide. The Harvard WFHN has unique expertise in areas focusing on: 1 .assessments of health that rely on state of the art biomarker and sleep-related actigraphy assessments and 2. a strong history of worksite studies especially in long term care and among low wage workers from diverse racial/ethnic backgrounds. Our pilot studies suggest that workers from occupations including nursing care, custodial and food preparation can be successfully recruited to studies with high response rates. Our results indicate that work family practices are [unreadable] [unreadable] strongly related to objective health indicators of CVD risk and sleep disruption. [unreadable] [unreadable] [unreadable]